COMPARISON OF HYDROSTATIC WEIGHING AND BODY VOLUME DISPLACEMENT

The present study will evaluate the ability of a new air displacement plethysmography technique for the measurement of body density. It is hypothesized that this technique is reliable and valid independent of age, gender, body composition,and fitness. Recrutiment is ongoing.